Data-Driven Approaches to Identify Biomarkers for Guiding Coronary Artery Bifurcation Lesion Interventions from Patient-Specific Hemodynamic Models

ABSTRACT
Coronary artery disease (CAD) is highly prevalent in the US, causing more than 360,000 deaths in 2017
alone. CAD is caused by plaques (a.k.a. lesions) that build up along the walls of coronary arteries, restricting
blood ﬂow. In 20% of cases, these lesions occur at arterial bifurcations. Treatment of coronary bifurcation le-
sions remains particularly challenging, as their stenting carries a higher risk for adverse cardiac events such as
in-stent restenosis, stent thrombosis, myocardial infarction, or need for recurrent percutaneous coronary inter-
vention (PCI). For single vessel lesions (not at bifurcations), the Fractional Flow Reserve Versus Angiography for
Multivessel Evaluation (FAME) trial played a critical role in establishing a biomarker (fractional ﬂow reserve, FFR)
to guide and improve their treatment. However, there is an urgent need for a classiﬁcation scheme to assess
physiological severity and ischemic burden of lesions at bifurcations, particularly in the side branches after main
branch intervention. Until this knowledge gap is corrected, patients with bifurcation lesions will continue to have
a signiﬁcantly higher rate of long-term cardiac complications compared to those with single, main branch lesions.
Current PCI protocols based on FFR for treating simpler main branch lesions do not translate into effective
protocols for more complicated bifurcation lesions. The difﬁculty in extracting similar metrics is due to the in-
creased complexity of the lesion geometry (typically consisting of two distinct lesions, one in the main branch and
one in the side branch) and stronger inﬂuence of the underlying patient anatomy. While it is known that treat-
ing the main branch lesion can improve the outcome, clear guidance is lacking regarding when to treat the side
branch. Our long-term goal is to establish a multi-level classiﬁcation system based on lesion- and patient-speciﬁc
features that can be used to guide treatment decisions with better precision, and ultimately to reduce the high
rate of adverse complications in patients with bifurcation lesions. Our central hypothesis is that criteria describing
bifurcation lesion anatomy can be identiﬁed to classify ischemic burden and, in turn, guide stenting decisions.
Through the use of a systematic, validated computational model, we can now accurately determine the contri-
bution of each anatomic feature to physiologic severity. We now have the computing power, validated tools, and
machine learning maturity required to undertake a large-scale, in silico study to isolate not only the inﬂuence of
individual features, but underlying relationships between sets of features. The major objective of this proposal is
to enable personalized guidance of bifurcation stenting procedures by identifying both the lesion-speciﬁc features
that inﬂuence functional severity as well as the patient-speciﬁc biomarkers that may exacerbate burden.

Public health relevance
As patients with bifurcation lesions have a higher rate of adverse cardiac complications such as in-stent restenosis, identification of robust biomarkers of functional severity is critical. We will draw on advances from fields of machine learning, parallel computing, and personalized simulation, to capture rich information from large-scale models and to identify precise biomarkers that are able to predict clinical measures for new individuals and help for intervention. Thus the proposed research is relevant to the part of the NIH’s mission that pertains to fostering new strategies for ultimately protecting and improving health.